Multi-component chlorination intervention to reduce neonatal infections in rural health facilities

SUMMARY
Neonatal mortality remains high in sub-Saharan Africa, where 43% of global neonatal deaths occur. In
rural, low-income health facilities, contaminated drinking water and environmental hygiene conditions put
newborns and their mothers at risk for healthcare-associated infections, including antibiotic resistant infections.
In Kenya, health facilities are typically limited to water treatment with manual, point-of-use products that require
extensive effort to use and are insufficient for the volumes of safe water required to provide quality healthcare.
Our team has developed a low-cost, in-line chlorination technology, the Venturi, that automatically doses chlorine
without moving parts or electricity, and is able to use chlorine produced by an off-the-shelf electrochlorinator,
which can produce chlorine disinfectant solution using only water, salt, and intermittent electricity.
We propose to conduct a cluster-randomized controlled trial across 30 health facilities to generate
rigorous evidence on the maternal and neonatal health benefits of chlorinated water supply paired with on-site
generation of chlorine for disinfection. This study combines our team’s expertise in engineering, epidemiology,
microbiology, and pediatric medicine to accomplish the following aims: 1) determine the impact of the intervention
on pathogenic and antibiotic resistant bacteria contamination in water supplies, high-touch surfaces, and
healthcare worker hands, 2) quantify intervention effects on gut colonization of mothers and neonates by a panel
of pathogenic and antibiotic resistant bacteria species linked to neonatal infection, using molecular and culture-
based methods, and 3) follow up with >20,000 mother-neonate dyads to measure intervention effects on
symptoms of severe bacterial infection in the first week of life.
Infection prevention through effective water, sanitation, and hygiene (WASH) has been cited by national
action plans as a key tool in the fight against antimicrobial resistance and, while global data show dire WASH
conditions in low- and middle-income (LMIC) health facilities, there exists very little guidance for implementing
effective interventions. This proposal is a time sensitive opportunity to leverage substantial philanthropic funding
to deliver a novel and scalable intervention to health facilities. The overarching goal is to generate actionable
evidence to inform investments in chlorination at health facilities to improve neonatal health and reduce the threat
of antibiotic resistant infections.

Public health relevance
Project Narrative Maternal and neonatal mortality remains high in sub-Saharan Africa, and infections are a leading cause of death. Poor water quality and highly contaminated surfaces in health care facility maternity wards are known to increase gut colonization with bacterial pathogens, including antibiotic resistant bacteria. This study will evaluate a novel intervention consisting of passively chlorinated water supply and on-site generation of chlorine disinfectant in health facilities to reduce environmental contamination, reduce colonization of mothers and neonates with sepsis-associated bacteria and antibiotic resistant microorganisms, and improve maternal and neonatal health.